Credentialing Models of Invasive Lobular Breast Cancer for Translational Research

Invasive lobular breast cancer (ILC) is the second most common histological subtype of breast cancer after the
more common invasive ductal breast cancer (IDC). In 2020, ILC will affect up to 40,000 patients in the US, and
if considered an independent malignancy is the 6th most frequent cancer in women. Loss of E-cadherin
(CDH1) is the pathognomonic feature of ILC, which leads to a single-file pattern infiltration of small discohesive
cells into the stroma. Patients with ILC suffer from late recurrences and metastasis to unique sites such as the
urogenital tract (e.g. ovary) and the gastrointestinal (GI) tract (e.g. peritoneum). Despite numerous studies
showing unique clinical, histopathological, and molecular features of ILC, clinical trials and guidelines mostly
ignore the unique aspects of ILC, and treat IDC and ILC as a single disease. Our long-term goal is to improve
outcome for patients with ILC, a disease associated with limited understanding and representing a great unmet
clinical need. ILC is currently understudied at least in part due to a lack of credentialed models and it is
currently unclear which ILC models are most appropriate to test clinically meaningful questions.
We will collaborate with the Cancer Dependency Map Project (DepMap - CCLE) and members of PDXNet to
comprehensively credential ILC models. We have established a team with complementary expertise in ILC
biology, rodent modeling, bioinformatics, immunology, pathology, medical oncology, and breast cancer
advocacy and will use innovative validation strategies to cross-compare in vitro and in vivo translational ILC
models. Our goal is to create a robust set of well-curated models that are credentialed to provide translationally
reliable information for evaluating targeted therapies in primary and metastatic ILC.
In Aim 1 we will molecularly characterize ILC models and compare them to human ILC. This will include 19 ILC
or ‘ILC-like’ cell lines, 20 primary ILC organoids, 8 patient derived xenografts, 2 homograft rodent models and 3
genetically engineered mouse models (GEMM). We will assess histopathology and perform comprehensive
genomic, epigenomic and transcriptomic analyses. In Aim 2 we will focus on in vitro growth phenotypes and in
vivo metastasis to determine which models recapitulate the unique growth pattern seen in human ILC. Since
we have recently sequenced unique sites of ILC metastasis (ovary, GI) in the human disease, we will compare
the molecular profile of our metastasis models to human ILC metastasis. Finally, Aim 3 will focus on
therapeutic efficacy. We will work with the Broad Institute to perform CRISPR and drug screening on ILC cell
lines and organoids and make all data available in the DepMap portal. In vivo we will assess endocrine therapy
response in homografts and compare the results to an ongoing ILC clinical trial led by our group. We will also
characterize the immune cell infiltrate and response to checkpoint inhibitors in homograft rodent ILC models in
order to assess their suitability for the study of therapies targeting the immune system.

Public health relevance
Invasive lobular breast cancer (ILC), which is characterized by the near universal loss of E-cadherin and unique growth pattern, accounts for 10-15% of all breast cancer (up to 40,000 new cases per year) and is understudied in part due to a lack of credentialed models in which to study the disease. Here we propose to comprehensively generate and characterize cell line, organoid, patient-derived xenograft, homograft and genetically engineered rodent models of ILC and compare them to the human disease. We will perform detailed genomic, epigenomic and transcriptomic analyses, phenotypic studies and therapeutic efficacy studies to test which models recapitulate the unique biology of human ILC, thereby credentialing them for future use in the study of ILC.